HDPTP

Program Summary/Abstract (HDPTP)
Project Title: IBT Hazardous Materials Worker Health and Safety Training
(HDPTP)
Under the HDPTP, the IBT Consortium will build institutional competency, increase community resilience, and
create a sustainable worker health and safety training program. Workers and community members engaged in
disaster response/recovery activities encounter myriad occupational hazards such as: slip, trips and falls, heat
illness, musculoskeletal, confined spaces, electrical hazards, exposures to chemicals, and exposure to
wildlife.Consequently, it is critically important for these workers and community members to receive training to
ensure that they are able to identify occupational hazards and able to take actions to protect themselves, their
coworkers and the surrounding environment.
The HDPTP will target workers and community members who work and live in disaster prone areas and are
likely to be involved in response and recovery activities.
The IBT Consortium proposes to recruit workers within the targeted population through relationships and
partnerships with employers, unions, community-based organizations, and 11 regional training centers to
conduct 310 classes for 3,960 workers during the 5-year funding period. The IBT Consortium is in a unique
position to deliver relevant, high quality health and safety training to workers due to our infrastructure, mobile
training capability, staffing, extensive experience, and expertise.
The long-term objectives and specific aims of the IBT Consortium are to increase worker, community, and
environmental safety and resilience by training workers to safely respond to natural disasters.

Public health relevance
Project Narrative (Overall) The IBT Consortium represents and has ready access to tens of thousands of workers throughout the U.S. who remediate hazardous waste sites, transport hazardous wastes, handle, package, transport and warehouse hazardous materials, and respond to hazardous materials releases. The IBT Consortium has over 1.3-million- member workforce that connects to employers, affiliates, communities, and individuals The IBT Consortium is staffed by a team of experienced worker health and safety training experts who specialize in industrial hygiene, curriculum development, adult education techniques, information technology, website and media development, data analysis, and craft-experienced worker-trainers. Through the IBT Consortium, the program has access to various stakeholders including: environmental groups, public health workers, railroad workers, and tribal entities, such as the Tribal Employment Rights Office (TERO) of the Confederated Tribes of the Umatilla Indian Reservation in the Pacific Northwest region. The combination of access to worker populations and institutional capacities enables the IBT Consortium to deliver high quality model training that complies with the NIEHS Minimum Criteria, applicable standards and regulations as promulgated by the Environmental Protection Agency (EPA), Occupational Safety and Health Administration (OSHA), and the Department of Homeland Security (DHS).